Engaging the subgenual cingulate with brain stimulation for depression

ABSTRACT
The subgenual anterior cingulate cortex (sgACC) has dominated the literature utilizing repetitive transcranial
magnetic stimulation (rTMS) to treat depression for good reason: treatment focusing on the frontal-sgACC
brain circuit is effective and changes in resting fMRI connectivity with the sgACC accompany symptom
improvements. However, it has not yet been proven that TMS actually engages the sgACC which would
support continued focus on this circuit at the exclusion of other potential targets from the fMRI literature. With
the application of interleaved TMS/fMRI, it is possible to capture brain responses caused by TMS to any brain
surface site. Using resting fMRI connectivity to guide TMS targeting, we seek to establish neuromodulation of
the sgACC pathway (R61, Aim 1) and the best connectivity pipeline for robustly engaging the sgACC (R61,
Aim 2). Upon establishing these successful benchmarks, the R33 phase will demonstrate that the sgACC
evoked response at baseline predicts depression improvement when treatment delivered to this same circuit
(R33, Aim1). To cement the relationship between modulation of the frontal-sgACC circuit with treatment and
depression improvement, we hypothesize an association between brain changes and clinical changes (R33,
Aim 2). We hypothesize that the R33 clinical associations with evoked brain responses will be established for
active but not for sham rTMS. Together, this research will elucidate basic mechanisms of rTMS treatment that
will accelerate brain circuit targeted neurotherapeutics.

Public health relevance
PROJECT NARRATIVE Repetitive transcranial magnetic stimulation (rTMS) is FDA cleared for treating depression that does not respond to antidepressant medication. Despite being a brain-based treatment, there is a gulf between knowledge from the brain imaging literature and how rTMS treatment is generally applied. We seek with this project to support a link between TMS evoked brain responses recorded during interleaved TMS/fMRI sessions and depression improvement to rTMS treatment.